Cardiovascular Health After Placental Abruption (CHAP)

Abstract
Placental abruption is an obstetrical complication defined as premature placental separation. Despite its elusive etiology,
it is believed to be the consequence of acute stimuli – ischemia, inflammation, and oxidative stress at the maternal‐fetal
interface – associated with rupture of the decidual artery, resulting in (premature) placental separation. The study of
abruption and maternal and newborn long‐term cardiovascular and hemorrhagic/thrombotic cerebrovascular events is
the central focus of the proposed project. We will examine the long‐term impact of abruption on rates of cardiovascular
and cerebrovascular morbidity and mortality in women and in their children. We will also investigate the relationship of
clinical classification (mild and severe forms) of abruption, risks based on abruption across successive pregnancies, and
abruption in twin pregnancies, on rates of cardiovascular and cerebrovascular events. We will undertake a causal
mediation analysis to evaluate the extent to which these associations may be mediated through (i) preterm delivery and
(ii) small for gestational age births. We will perform this analysis by clinical classification of abruption and estimate the
extent of mediation following corrections for both measured (socio‐demographic characteristics, including maternal
smoking, comorbid medical conditions, and obstetrical events), and unmeasured confounding. A unique aspect of this
project will be to identify, through applications of Support Vector Machines and Deep Learning algorithms, subsets of
women at high risk for abruption and cardiovascular and cerebrovascular mortality and morbidity. Finally, we will examine
whether maternal race/ethnicity and socioeconomic status are effect measure modifiers of the association between
abruption and risks of cardiovascular and cerebrovascular events. We propose to address these aims through a large
population‐based epidemiologic study, utilizing data from the Myocardial Infarction Data Acquisition System (MIDAS), a
New Jersey statewide database of all patients admitted to all non‐federal acute care hospitals in NJ with a CVD diagnosis,
with longitudinal follow‐up of up to 30 years. The MIDAS data will be linked to the NJ fetal death and linked live birth‐
infant death data with associated maternal and newborn hospitalization data between 1980‐2017 to create one of the
largest and most comprehensive databases in the US to evaluate the extent to which sentinel events in pregnancy impart
lasting risk for women's and children's health later in life. This project will provide unprecedented opportunities to address
public health, policy implications and clinical screening recommendations of women during the period following delivery
regarding risk susceptibility to cardiovascular and cerebrovascular disease.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH SIGNIFICANCE) The overarching goal of this project is to examine the associations between placental abruption and risks of cardiovascular and cerebrovascular morbidity and mortality later in life. The project will focus on overall associations, as well as identifying subsets of women at high risk based on abruption severity, recurrent abruptions, gestational age at delivery, and fetal growth restriction. This project will provide unprecedented opportunities to address public health, and policy implications regarding women's health, and clinical screening recommendations of women during the period following delivery regarding risk susceptibility to cardiovascular and cerebrovascular diseases.